Coordinated cARe paiN mAnagement Technology ImplementatiON (CARNATION)

Chronic musculoskeletal pain conditions – common, disabling, costly public health problems –
disproportionally impact persons of lower socioeconomic status and are a primary driver of
medical care. Current chronic pain care guidelines recommend multimodal, integrative pain
management (IPM) involving non-opioid pharmacological options along with non-pharmacologic
therapies (physical interventions, psychological approaches, and complementary and integrative
healthcare). Community health centers (CHCs) serving low-income patients face substantial
time and resource constraints in ensuring that patients receive guideline-concordant IPM
services. Recent expansion of state Medicaid reimbursement for non-opioid pain management
services and Medicare coverage for pain care management could help connect CHC patients
(most of whom are publicly insured or uninsured) with IPM-congruent services. However, CHC
staff lack the health information technology (HIT) infrastructure necessary to track and
coordinate such services for their patients, as well as the support needed to use such tools
systematically. The new Compass Rose care management application was recently activated in
the Epic electronic health record (EHR) platform shared by ~2,000 CHCs in 43 states. This
EHR-based tool supports care coordination such as that needed for IPM-congruent care, but
integrating it into CHC care processes involves complex clinic-wide practice changes requiring
implementation support. Effective strategies for providing such support are needed. To identify
and optimize such strategies, we will partner with this national CHC network to test a multi-
component implementation support intervention designed to enable CHCs’ systematic use of
Compass Rose for coordinating primary care-based IPM-congruent pain care. This hybrid type
3 implementation-effectiveness randomized trial will: 1. Engage key advisors to tailor Compass
Rose to optimize its facilitation of IPM-congruent care and refine the implementation support
intervention components; 2. Test the intervention package’s impact on CHCs’ use of the tailored
HIT tools and on patient pain-related outcomes; and 3. Conduct formative evaluation and
budget impact analyses to understand and explain intervention Reach, Effectiveness, Adoption,
Implementation and Maintenance. The study will generate urgently needed evidence on how to
make IPM care available in CHCs whose limited resources present barriers to the delivery and
coordination of such care. Results will provide empirically-based guidance on how to optimize
HIT infrastructure and provide related support for its uptake to enhance the primary care-based
delivery of coordinated multidisciplinary pain care in CHC populations.

Public health relevance
Project Narrative Primary care providers serving populations experiencing health disparities often struggle to effectively link their patients who have chronic pain with the multidisciplinary services that are essential to effective pain management. Information technology infrastructure that coordinates this multi-component care – and workflow redesign that supports use of such technologies – are both critically needed, as are effective strategies for helping clinics adopt such practice changes. This study will evaluate the effectiveness of support interventions co-designed to help care management teams implement use of electronic health record-based functionalities for coordination of multidisciplinary pain services for primary care community health center patients.